Diabetes Prevention Phenotyping Core

ABSTRACT- DIABETES PREVENTION PHENOTYPING CORE
The Diabetes Prevention Phenotyping Core (DPPC) within the University of Kentucky Diabetes Prevention
COBRE (UK-DPC) is a specialized human and rodent experimental facility that will offer critical infrastructure
and technical support to empower junior faculty members and the broader University of Kentucky diabetes
prevention research community for project success. The DPPC will supply comprehensive design and support
for diabetes prevention research projects by offering seasoned expertise in experimental design, execution,
and results interpretation for addressing research questions in whole organisms and biological samples from
both human subjects and rodents. The DPPC will also pilot and establish new techniques in diabetes
prevention research to facilitate the adoption of new technologies. The DPPC will be unique on campus
because of its commitment to offering services, techniques, and specialized equipment that are not currently
available within the institution. These include dedicated personnel and space for human and rodent metabolic
clamp measurements, human tissue biopsies, clinical coordination, pancreatic islet isolation from rodents, and
training in basic methods of rodent metabolic characterization and clinical research concepts. These
capabilities will foster technical and conceptual independence of junior investigators and grow our base of
researchers answering important questions in diabetes prevention through state-of-the art approaches coupled
with technological innovation.
The support services offered by the DPPC are tailored to address the specific requirements of the proposed
research project leader’s (RPL) scientific projects, and to offer support for expected projects of future RPL and
pilot project leader (PPL) studies in diabetes prevention. These services have been strategically aligned to
seamlessly integrate with and complement the research activities in UK-DPC laboratories and beyond. The
DPPC will also serve as a pivotal recruitment tool for junior faculty candidates and RPLs as the first cohort of
RPLs and PPLs transition to independent funding. The DPPC will encourage junior investigators to enhance
their studies in pre-clinical models with complementary human subjects' research by lowering the barrier of
entry into translational research study design and methodologies. We expect the long-term impact of the DPPC
will be to substantially enhance the competitiveness of applications for extramural funding while establishing
the University of Kentucky as a technological leader in diabetes prevention research.